The neuroanatomical basis for face processing deficits in autism spectrum disorder

Autism Spectrum Disorder (ASD) affects 1:59 children and is associated with a heterogeneous mix of disabling
and difficult to manage symptoms; however, accurate localization of specific symptoms may allow for novel
individualized therapies. To investigate the common symptom of poor face recognition, we recently used a new
technique, `lesion network mapping', to identify a brain network that is consistently and specifically associated
with face recognition deficits in patients with acquired prosopagnosia (face blindness after stroke).This
proposal investigates whether there a common circuit for the transdiagnostic symptom/construct of face
recognition impairment, i.e., are brain regions affected by acquired prosopagnosia also affected in children with
ASD who display atypical face processing. This proposal addresses two key gaps in current knowledge: 1) do
brain regions implicated by acquired prosopagnosia also demonstrate abnormalities in patients with ASD that
correlate with face processing ability; and 2) do specific brain connectivity differences explain some or all of the
observed heterogenicity in face-evoked brain activity, face-recognition abilities, and potentially social affect in
individuals with ASD. Presently, no publicly available dataset contains the complete set of measures to
address these gaps. This application proposes prospective data collection to address this gap. Adolescent
subjects, with and without ASD, will undergo behavioral assessments of face processing ability, social
impairment, and ASD symptom severity along with structural, task, and `resting-state' functional MRI
acquisition. Recruitment will be enriched with subjects with known face recognition difficulties to capture a
range of face processing abilities. This proposal has the potential to generate biomarkers or treatment targets
for trials of therapeutic intervention for face recognition deficits across populations. Furthermore, if successful,
this project will provide a model for identifying the neuroanatomy for many symptoms present in ASD and other
neurodevelopmental disorders. This Mentored Patient-Oriented Career Development Award application directly
aligns with the National Institute of Mental Health Strategic Objectives (SOs), as it will help define the
connectome abnormalities of face recognition impairment (SO1.3), inform the development of early biomarkers
predictive of face recognition impairment (SO2.2), and shed light on potential mechanistic treatment targets to
improve these abilities (SO3.1). The proposal also provides important opportunities for training and career
development to enable Dr. Cohen to become an independent investigator. Dr. Cohen has experience in using
neuroimaging tools to understand brain connectivity, and with this award, he will gain training in: (1) the design,
acquisition, and analysis of a MRI-based study in a pediatric clinical population; (2) the selection, collection,
and analysis of pediatric behavioral assessments; and (3) the validation of lesion-based neuroimaging findings.
Ultimately, the proposed program will provide a strong foundation for an independent research career devoted
to the understanding and treatment of symptoms in ASD and other neurodevelopmental disorders.

Public health relevance
PROJECT NARRATIVE Individuals with autism spectrum disorder have a heterogeneous mix of symptoms; one of which is poor performance of face recognition tasks. This proposal investigates the cause of face processing difficulties in ASD by leveraging information from patients with acquired prosopagnosia and prospective collection of MRI and behavioral data in adolescent subjects across a range of face-processing abilities. The findings of this proposal will inform the development of biomarkers and treatment targets for trials of therapeutic intervention for face processing deficits across diagnoses.